THE EFFECT OF B2 AGONIST ON MUSCLE MASS IN PROGRESSIVE MUSCLE WASTING DISORDER

This study is being conducted to reevaluate the long term effects of albuterol on muscle strength and muscle mass on FSH Dystrophy.